Administrative Core

Administrative Core ABSTRACT
The Administrative Core will provide leadership and guidance to the Texas A&M Center for Environmental
Health Research (TiCER) to ensure excellence of research integration, community engagement, research
translation, and career development. The overall theme of the Center is “Enhancing Public Health by Identifying,
Understanding, and Reducing Adverse Environmental Health Risks.” The Administrative Core will serve as the
focal point for the Center and provide the support infrastructure to promote cross-­discipline interactions among
all members, facility cores, and external stakeholders. The Administrative Core will be centrally located on the
Texas A&M University campus. The responsibilities of the Administrative Core, led by the Program Committee,
consisting of the Center Director, Deputy Director, Center Administrator, Facility Core principal investigators and
theme leaders, will be: (i) planning Center activities;; (ii) evaluating progress and considering solutions for
challenges;; (iii) improving Center integration;; (iv) advising on personnel matters;; (v) assessing quality
management/assurance;; (vi) organizing the annual retreat;; and (vii) evaluating community engagement, training,
and research translation activities. will be to facilitate regular interactions among Center members, track products
and outcomes, develop and plan future activities, and guide and sustain growth of environmental health research
at Texas A&M. The Program Committee will use an Internal Advisory Board of senior Texas A&M administrators
and an External Advisory Board of eminent environmental health researchers in advisory capacities to ensure
that research, outreach, career development, and translation goals and objectives are being met. The Center
will achieve its goals through four aims: 1) Provide effective center leadership;; 2) Maintain an active membership;;
3) Enhance coordination, integration, and translation of research;; and 4) Promote career development.